Pathways to Lower Urinary Tract Symptoms Prevention in Adolescent and Adult Women.

PROJECT SUMMARY/ABSTRACT
Lower urinary tract symptoms (LUTS) encompass a wide range of symptoms, including urinary incontinence,
urinary frequency, urgency, nocturia, bladder pain, urinary tract infections, and voiding symptoms. There is an
extensive literature describing the many approaches to treatment of LUTS, but less is known about prevention.
The “Prevention of Lower Urinary Tract Symptoms (PLUS) Consortium is a transdisciplinary scientific network
established to expand research beyond the treatment of LUTS to promotion of bladder health and prevention
of LUTS in adolescents and women across the life course. Despite many epidemiologic studies on risk factors
for LUTS, little research has examined factors that promote bladder health. One key gap is in understanding of
what defines healthy voiding and toileting behaviors and how these behaviors affect bladder health over time.
Our overarching hypothesis is that maladaptive voiding and toileting behaviors contribute to poorer bladder
health among adolescent and adult women. The primary aim of this proposal is to continue our participation
as a clinical research center in PLUS and collaborate with other centers to design and conduct a longitudinal
cohort study that lays the foundation for developing future prevention interventions to promote bladder health
and prevent LUTS. The University of Alabama at Birmingham (UAB) team is an interdisciplinary group of
investigators with collective expertise in LUTS clinical research, behavioral medicine, geriatric medicine,
adolescent medicine, prevention science, public health, epidemiology, biostatistics, health disparities, and
medical sociology. Our team is poised to contribute expertise on 1) design and conduct of longitudinal studies,
2) evaluation and treatment of LUTS (including clinical examination and bio-specimen collection), 3) qualitative
methods, 4) recruitment and retention of diverse samples of participants with/without LUTS, and 5) community
engagement. The second aim is to build on the longitudinal cohort study to examine two additional potential
risk/protective factors for bladder health and LUTS that are plausible targets for future intervention studies. In
addition to testing a number of other factors in the national cohort, we propose to examine 1) the role of
neighborhood disadvantage in relation to voiding and toileting behaviors, using the Area Deprivation Index, and
2) the association of functional ability with voiding and toileting behaviors using gait speed and bio-markers of
inflammation. Understanding the role of these factors will support the development of models for identifying at-
risk individuals and groups, as well as inform education initiatives. The third aim is to develop and conduct
pilot foundational studies related to promoting healthy voiding and toileting behaviors. The first study aims to
understand voiding and toileting behaviors across environments among adolescents using a mobile application
with geographic information system mapping. The second aims to develop a mobile health self-management
educational program for promoting healthy bladder behaviors. These projects will lay the foundation for the
development of future research on interventions to promote bladder health across the life course.

Public health relevance
NARRATIVE The “Prevention of Lower Urinary Tract Symptoms” (PLUS) Research Consortium is a transdisciplinary U.S. scientific network established to expand research beyond the detection and treatment of LUTS to the promotion of bladder health and prevention of LUTS in adolescents and women across the life course. Our overarching hypothesis is that healthy voiding and toileting behaviors contribute to improved bladder health and decreased LUTS for adolescent and adult women. Our transdisciplinary PLUS team at the University of Alabama at Birmingham (UAB) proposes three interrelated pathways related to healthy voiding and toileting behaviors that may impact bladder health and prevention of LUTS: (1) conducting a longitudinal cohort study of women to assess bladder health and LUTS across the life course; (2) increase understanding of risk and protective factors to inform plausible intervention targets for healthy voiding and toileting behaviors; and (3) developing delivery models for future bladder health education programming.